REGULATION OF HUMAN IMMUNE RESPONSE BY COMPLEMENT

Complement factors and breakdown products block the differentiation of human B lymphocytes in vitro. Complement components and receptors also affect the generation of cytotoxic T cells in vitro. Understanding of the mechanism of regulation of immune responses by complement is crucial for the understanding of the immunopathogenesis of autoimmune diseases since they are frequently associated with complement activation and depression of complement factor levels.